Administrative Core

DACCOTA-Administrative Core
Summary: The objective of the Adminstrative Core is to centralize the resources necessary to ensure the
success of the Dakota Cancer Collaborative on Translational Activity (DACCOTA). This core will create
integrated organizational governance to engage participating institutions in promoting the vision of the
DACCOTA. Members of our center will function as a team rather than as individuals to achieve our
objectives, with our guiding principle being the search for benefit for our patients. The Administrative Core
will provide leadership and an administrative structure that supports day-to-day operations, coordinates,
and oversees efforts to achieve the overall goals of the DACCOTA. This core will also foster collaborative
engagement between partners and build an internal and external environment conducive to clinical and
translational cancer research. To enhance the productivity of our clinical and translational investigators,
this core will also leverage existing resources at the affiliated institutions as well as establish new cores
and programs.

Public health relevance
Narrative: The DACCOTA will partner regional universities, institutes, and clinical entities to ensure researchers’ needs are met through an integrated research support structure. The Administrative Core will be responsible for the business administration and overall daily management of the center’s operations. The core leaders will report directly to Dr. Basson, the DACCOTA Director and PI. Specifically, the Administrative Core will manage the operational and financial aspects of the grant, track progress, and communicate effectively with the group and partner institutions to ensure success.